Administrative Core

CORE SUMMARY
The Administrative Core will provide administrative and project management support to the entire Program,
and to ensure all projects and cores adhere to scientific, fiscal, and NIH reporting objectives. These functions
will be crucial for the successful execution of the Program, given the complexity of the proposed work, and the
extensive sharing of data and reagents that is envisioned amongst the different projects. Though each project
alone will provide important information to the field at large, extensive synergy and coordination is required to
completely realize the full potential of the overall Program. The Administrative Core will employ the efforts of a
Project Manager (PM) and a variety of project management functions to coordinate and support each project.
These will include formal program planning and monitoring, status reporting and project scheduling. In addition,
a specific goal and function of the Administrative Core will be to facilitate and assist communication amongst
PIs and projects, including information sharing, preparation and submission of manuscripts, and coordination
and scheduling of meetings and teleconferences. In parallel with active management of communication and
coordination amongst projects, a series of activities will ensure productive communication with the NIH and
appointed officers. This will entail preparation and submission of NIH reports and facilitate attendance of
required team leaders at LJI and NIH meetings and/or conference calls. Finally, the Administrative Core will
oversee compliance of the overall Program and individual projects and cores with respect to fiscal and
reporting obligations.